Identifying the Bordetella PlrSR regulon

PROJECT SUMMARY
Pertussis (aka whooping cough) is a serious, re-emerging public health concern despite
available vaccines. The acellular vaccine against Bordetella pertussis, used in the U.S. since the
1990s, prevents serious disease, but not colonization or transmission, resulting in a larger reservoir
from which infants, who are most vulnerable, can be infected. New vaccines that protect against both
colonization and disease are needed.
The BvgAS and PlrSR two-component systems control Bordetella virulence. The BvgAS
two-component regulatory system (TCS) has long been considered the master regulator of Bordetella
virulence. It controls production of all know protein virulence factors, including those in the acellular
vaccine. We discovered another TCS, called PlrSR, that is essential for Bordetella viability and for
BvgAS activity in the lower respiratory tract (LRT). We found that PlrSR is required for LRT infection
even when BvgAS is constitutively active, indicating that PlrSR controls expression of unidentified but
critical virulence functions independently of BvgAS. These currently unknown virulence factors
could serve as therapeutic targets or new vaccine components, and hence their identification
is critical for controlling pertussis in the future.
Drs. Cotter and Julio are experts in Bordetella pathogenesis and molecular biology, and Dr.
Bourret is an expert in TCS biochemistry. Together, we have characterized PlrS and PlrR proteins
biochemically and have discovered a way to bypass the apparent essentiality of plrS in vitro so that
we can construct strains to collect gene expression data without knowing the stimuli sensed by PlrS.
In Aim 1, we will identify genes regulated by PlrSR using RNA-Seq to reveal positive or negative
regulation, and ChIP-Seq to reveal direct or indirect regulation. In Aim 2, we will investigate PlrSR
signaling by making reporter fusions to key PlrSR-regulated genes and assessing responses to
physiologically relevant stimuli, as well as the consequences of using PlrS lacking PDC or PAS
sensory domains.
Identification of the PlrSR regulon is low risk/high reward and will lay the foundation for a
R01 project. The proposed methods are well-established, suggesting a high probability of achieving
our Aims. Identifying the PlrSR regulon will be transformative in understanding Bordetella
pathogenesis and enable a future R01 project in which we can determine (i) why PlrR is essential for
viability, (ii) the roles of PlrSR regulated gene products in LRT infection by Bordetella, (iii) how PlrSR
regulates gene expression, (iv) connections between the PlrSR and BvgAS TCSs, and (v) perhaps
gain insight into the stimuli sensed by PlrS.

Public health relevance
PROJECT NARRATIVE This project combines the expertise of three laboratories to identify genes regulated by the Bordetella PlrSR two-component regulatory system. Our recent data indicate that one or more PlrSR-regulated genes is critical for bacterial survival in the lower respiratory tract. The gene products could serve as therapeutic targets or new vaccine components for treating or preventing pertussis (aka whooping cough), a serious respiratory illness that is increasing in the United States and other countries that use acellular pertussis vaccines.